Engineered Lipid Nanoparticles and Microgel Matrix to Program Th1/Th2 Immune Response

PROJECT SUMMARY
The overall objectives of this study are to (1) develop mRNA lipid nanoparticle (LNP) formulations capable
of eliciting dual or biased Type 1 T helper (Th1) and/or Type 2 T helper (Th2) immune responses via a machine
learning-aided screening platform, (2) engineer mRNA LNP-
loaded microgels as an immunostimulatory niche in
vivo to recruit and transfect host immune cells and potentiate antigen-specific immune responses, and (3)
demonstrate the efficacy and safety of this new LNP-based vaccine platform in murine cancer models. The
success of mRNA COVID-19 vaccines utilizing lipid nanoparticle (LNP) delivery has underscored the potential
of mRNA LNP-based cancer vaccines in advancing immunotherapy by training the immune system to respond
effectively to tumor antigens. To maximize their potency in eliciting robust immune responses for cancer
immunotherapy, it is important to engineer effective approaches for systematic programming of immune
activation profile via optimization of LNP compositions and improving delivery for mRNA LNP vaccines. Our
preliminary data have demonstrated that LNP compositions and helper lipid structure influence the polarization
of immune activation, and LNPs with dual Th1-plus-Th2 activation profile yielded the most potent antitumor
efficacy in mouse tumor models. In addition, a candidate mRNA LNP vaccine loaded into a nanofiber-based
microgel matrix, which facilitated recruitment and retention of host immune cells, enhanced antigen presentation,
and elicited equally strong anti-tumor response with a single dose compared to a standard three-dose
immunization regimen. In this proposed study, we will first optimize LNP composition for efficient transfection of
antigen-encoding mRNA into antigen-presenting cells (APCs) and non-APCs via an machine learning-guided,
iterative design-build-screen/test-learn process, and evaluate antigen presentation, and immune activation
profiles in vivo; then develop an LNP-incorporated nanofiber microgel matrix termed LiNx as an
immunostimulatory niche for recruitment of host immune cells and assess gene delivery efficiency and immune
response profiles; and finally demonstrate the therapeutic efficacy and biosafety of the optimized LNPs and LiNx
in suppressing tumor growth in therapeutic models of melanoma, lymphoma, and colon carcinoma in mice, as
well as an orthotopic, immunoquiescent, pancreatic cancer mouse model. The innovation in this study lies in
programming the immune activation profile generated by mRNA LNP vaccine by tunning cell-preferential
transfection activity of LNPs and engineering an immunostimulatory niche using a nanofiber microgel matrix to
recruit and retain host immune cells and deliver LNP vaccines, thus potentiating the therapeutic efficacy against
cancer. Findings from this study can inspire rational design of new mRNA-based immunotherapies for the
treatment of cancer and other diseases.

Public health relevance
PROJECT NARRATIVE This study aims to develop potent mRNA lipid nanoparticles (LNPs) with programmable Th1/Th2 immune activation profile, engineer a nanofiber microgel-based immunostimulatory niche to improve the delivery of LNP vaccines and boost the immune response, and evaluate their therapeutic efficacy in various mouse cancer models. Findings from this study will inspire the development of new mRNA LNP-based immunotherapies.